Cytoskeletal compartmentalization of apoptotic signaling

PROJECT SUMMARY
The actin cytoskeleton impacts virtually every function of a human cell. Sophisticated regulatory mechanisms
ensure that actin polymerizes when and where it is needed, and the assembly of actin filaments de novo is
driven by proteins called nucleation factors. While the cytoskeleton is known to provide structure and generate
forces in cellular processes that maintain viability, how it affects programmed cell death in response to stress is
not well understood. To address this question, we are investigating the mechanisms by which actin nucleation
factors from the mammalian Wiskott-Aldrich Syndrome Protein (WASP) family control apoptosis following DNA
damage. Our recent studies demonstrate that the WASP-family members JMY and WHAMM activate the
Arp2/3 complex to assemble a juxtanuclear F-actin-rich territory that regulates apoptotic signaling. The
cytoskeletal territory (I) serves as a compartment for coupling the biogenesis of apoptosomes to the localized
processing of caspases, and (II) sequesters the active caspases to temporarily protect the rest of the cell from
proteolytic cleavage. However, the molecular interactions between the apoptotic components and cytoskeletal
factors are not known. The specific goals of this project are to (1) define how apoptosome proteins and the
actin nucleation machinery interact in early apoptosis, and (2) determine how caspases disrupt F-actin-rich
territories to execute terminal apoptosis. To accomplish the first goal, we will (a) deplete the core apoptosome
components cytochrome c and/or Apaf-1 and define the localization patterns of JMY, WHAMM, and their
functional domains in fixed and live apoptotic cells; (b) characterize the physical interactions between
apoptosomal proteins and actin nucleation factors in vitro; (c) systematically quantify the abilities of purified
JMY, WHAMM, and Arp2/3 complex to polymerize actin in isolation, in the presence of each other, and in a
cytochrome c-regulated manner in vitro; and (d) measure the effects of precise JMY and WHAMM mutants on
actin assembly, apoptosome organization, and caspase activation in cells. To accomplish the second goal, we
will (a) deplete or mutate several caspases to identify the ones needed for dismantling F-actin-rich territories in
cells; (b) determine if caspases can cleave F-actin, G-actin, and actin-binding proteins in vitro; (c) define the
roles of actin crosslinking, bundling, capping, severing, and depolymerizing proteins on territory stability and
localization of a caspase inhibitor in cells; and (d) ascertain whether disease-associated actin mutants are
resistant to caspase cleavage and affect terminal apoptotic signaling in cells. Collectively, our results will
provide new insights into the molecular mechanisms of communication between key components of the
intrinsic apoptotic signaling cascade and the actin cytoskeleton.

Public health relevance
PROJECT NARRATIVE The cytoskeleton (“cell skeleton”) is crucial for organizing our cells and allowing them to adapt to changing conditions. Proteins called actin nucleation factors are required for assembling the cytoskeleton in processes that maintain cell viability, but how the factors control programmed cell death – apoptosis – is not understood. To discover how the cytoskeleton enables the proper cellular responses to DNA damage, the goal of this research project is to determine how actin nucleation factors interact with proteins that promote apoptosis.